timsTOF HT LC-MS System for UR Proteomics Research

Abstract
We are requesting funds for the purchase of a timsTOF HT mass spectrometry (MS) and liquid
chromatography system (Bruker) to be used for qualitative and quantitative proteomic analyses. This
instrument will greatly expand the proteomic capabilities of the University of Rochester Mass Spectrometry
Resource Laboratory (MSRL) and the services it offers to its user-base throughout the University of Rochester
and Western New York. Currently, the existing MS instruments at the MSRL are being used at full capacity
and there is a critical need for additional modernized instrumentation to alleviate project backlogs and take
advantage of recent advances in label-free Data Independent Acquisition (DIA) proteomics. The acquisition
of the timsTOF will augment our aging “3D” mass spectrometer (capable of detection of ions based LC
retention time, mass to charge and MS/MS fingerprint) with a “4D” ion mobility platform capable of additional
separation based on collision cross-section (CCS) properties of ions.
Recent advances in mass spectrometry have provided powerful tools for high-throughput analysis of proteins
that are widely employed in medical and biological research. Proteomic analyses are typically used for
discovery applications and in clinical or analytical screens that require large-scale target detection and
quantification of complex protein mixtures. Due to its potential for high impact on existing NIH-funded research
programs and Centers, the University of Rochester Medical Center (URMC) has targeted proteomics as an
area of critical development. The University's commitment to developing and supporting the MSRL has been
essential for providing accessibility to modern mass spectrometry resources, services and expertise for the
University of Rochester and Western New York research communities. The facility has experienced a
dramatic increase in demand in recent years, spurred in part by an overall shortage of accessibility to high-
end mass spectrometers in the region.
The requested timsTOF HT mass spectrometer is a versatile instrument that excels at high-throughput
quantitative proteomic applications, at a level beyond the capabilities of the current mass spectrometers in
the core facility. Specifically, the timsTOF instrument offers high-capacity Trapped Ion Mobility (TIMS)
analyzer, enables Parallel Accumulation and Serial Fragmentation (PASEF) and accurate, reproducible ion
mobility separation and CCS determination. Importantly, the instrument can achieve sequencing speeds up
to 150 Hz and 60,000 (FWHM) resolution at 1222 m/z. This rate of data acquisition far exceeds our current
instrument and will enable significant enhancements in our project turnaround times. In this application, 9
major users and 4 minor users provide project descriptions that impact at least 20 NIH research grants. The
diversity of users highlights the importance of this technology and the unmet level of need that will be
addressed by the instrument.
The need for sensitive high-throughput, high-resolution mass spectrometry is rapidly growing in the Medical
Center and the College that encompass over 45 departments and research centers, and over 800 research
laboratories. To ensure the highest level of access to proteomic technology and services, the requested
instrument will be housed in the URMC Mass Spectrometry Resource Laboratory. Three dedicated core staff
members will run the instrument, and the core staff and core director will manage projects, provide consulting,
analyze data, and assist users with data interpretation and processing. Data storage, analysis, and processing
will be performed at the University of Rochester's Center for Integrated Research Computing (CIRC), which
manages a 144-core processor server for the facility. Institutional support and oversight will ensure that state-
of-the-art mass spectrometry services are developed and accessible to the research community.

Public health relevance
Project Narrative Mass spectrometry is a powerful and robust technique for the analysis and quantification of complex collection of proteins, peptides, lipids, and small molecule metabolites. Currently, there is only a single mass spectrometer at the University of Rochester (UR) available for proteomic experiments. This instrument is currently being used at full capacity and lacks functional capabilities that are required or advantageous for several ongoing NIH-funded projects being conducted by the user-base of the UR Mass Spectrometry Resource Laboratory (MSRL). The proposed purchase of the timsTOF HT mass spectrometry system will facilitate proteomic experiments at UR by providing researchers a suite of novel tools that take advantage of the Trapped Ion Mobility (TIMS) analyzer and Parallel Accumulation and Serial Fragmentation (PASEF) features of the instrument. Specifically, the rapid sequencing speeds of the instrument will greatly alleviate project backlogs, reduce turnaround times and bring down the per-experiment costs of proteomics projects. These capabilities will enhance the ability of UR researchers to conduct large-scale proteomic experiments that require high proteome coverage and large number of samples and replicates. A number of projects described by the users of this instrument have clinical implications and will be analyzing proteomes within disease models that have direct relevance to the development of therapies that can improve human health. These projects, which are funded by 20 NIH grants, either require or will be significantly aided by the requested timsTOF HT instrument.